Dual Targeting Mitochondria and GPCR in Retinal Protection

PROJECT SUMMARY
Treatment for retinal degeneration that deteriorates photoreceptors and retinal pigment epithelium (RPE) cells
remains limited to date. A significant challenge for therapeutic design in retinal protection is the complexity of
degenerative mechanism. Single target intervention would not be effective to slow down or modify the
degenerative course due to compensatory mechanisms of disease-related pathways. Multi-target intervention is
increasingly important for effective treatment of complex disease including neurodegeneration. However,
compounds with bioactivity that can intervene more than one disease-related pathways in retinal degeneration
have not been explored. In this proposal, we will conduct in vivo therapeutic testing of a multi-target drug (CM-
20) in retinal protection via dual targeting both mitochondria and a G-protein coupled receptor (GPCR) to improve
mitochondrial function and biogenesis and to mitigate retinal oxidative damage. Two mouse models of retinal
degeneration will be used. One is an environmental stressor-induced retinal degeneration, and the other one is
a genetic model of inherited retinal disease. We will evaluate efficacy of CM-20 in protecting outer retina and
mitochondria and in reducing retinal oxidative stress. Positive outcomes would justify efficacy clinical trial in
human retinal degeneration and provide mechanistic knowledge in mechanism of action.

Public health relevance
PROJECT NARRATIVE Retinal degeneration such as age-related macular degeneration (AMD) and inherited retinal diseases collectively represents a leading cause of low vision and blindness in the United States. At present, there is no cure for AMD and inherited retinal diseases. Retinal degeneration involves complex degenerative mechanisms. Single target drugs would be not effective in treatment. This proposal tests the therapeutic potential of a multi-target drug in retinal protection through dual targeting mitochondria and a G-protein coupled receptor (GPCR) to protect retina from degeneration associated with oxidative stress and mitochondrial dysfunction, which are key pathogenic events in retinal degeneration.